Mechanism and treatment of Wilms Tumors caused by CTR9 mutations

PROJECT SUMMARY/ABSTRACT
Wilms tumor (WT) is the most common pediatric cancer of the urinary tract. Although the overall prognosis for
WT patients is generally favorable after chemotherapy, relapse and deaths still occur in a significant proportion
of patients. Therefore, there is a critical need to elucidate the molecular mechanisms underlying the disease
causal mutations and develop better treatments. Around 30 gene mutations have been associated with WT.
CTR9 germline mutations were identified in some WT families. The mutations caused alternative splicing and
deletion of exon 9 of CTR9. However, how one missing exon contributes to the initiation of WT is unknown.
CTR9 is the scaffold protein of the PAF complex, which has been well-characterized to regulate multiple steps
in transcription. We have modeled the CTR9 exon 9 deletion in an epithelial WT cell line, WiT-49, and found
that WiT-49 acquires stem cell features when exon 9 of CTR9 is deleted. When WiT-49 exon 9 deletion cells
are implanted into the kidney capsules of mice, they grow more aggressively than parental cells. Gene
expression and biochemical analyses uncovered that exon 9 deletion of CTR9 results in profound changes in
gene expression and disruption of the integrity of the transcription elongation complex. Flag-CTR9, but not
Flag-CTR9exon9, could pull down Elongin A (ELOA) and its associated splicing factors such as SF3B3 and
SF3A1. We hypothesize that exon 9 deletion of CTR9 blocks kidney-specific differentiation by dislodging
Elongin complex and disrupting transcriptional elongation, resulting in development of WT. We have
engineered cell lines to delineate how exon 9 deletion of CTR9 results in the disturbance of transcriptional
elongation and alternative mRNA splicing. Our recent studies have shown that CTR9 is essential for precluding
the repressive chromatin from spreading by counteracting the activity of EZH2. Therefore, we will also examine
if exon 9 deletion of CTR9 acquires stem cell properties to WiT-49 and renders cells sensitive to EZH2
inhibitors and inhibitors of splicing machinery. Successful completion of this project is expected to enhance the
understanding of pathogenesis of WT caused by CTR9 mutations and establish the invaluable experimental
platform for identifying effective therapies for WT.

Public health relevance
PROJECT NARRATIVE Wilms tumor (WT) is the second most common solid pediatric cancer in children of the ages from 2 to 4. Although WT patients have a favorable prognosis, ~50% of patients with blastemal WT will experience recurrence. This study focuses on elucidating the molecular mechanism of pathogenesis of WT caused by genetic perturbation of CTR9 and identifying effective treatments of children with aggressive WT.